Brain serotonin neuron gene regulatory networks and chromatin architecture

Precise spatiotemporal control of gene expression is crucial throughout life for maturation of postmitotic
neuronal function and preservation of brain health. Although continuously expressed neuronal transcription
factors termed terminal selectors, such as Pet1 and Lxm1b, are key regulators of gene expression across fetal
and postnatal stages of life the underlying molecular mechanisms through which they control stage specific
neuronal gene expression are poorly understood. Here, we aim to fill this gap by comprehensively investigating
terminal selector function in postmitotic serotonin (5-HT) neurons. Pet1 and Lmx1b’s control of serotonergic
gene expression is of broad interest as 5-HT has wide-ranging modulatory effects on central neural circuitry
and altered serotonergic gene expression has been implicated in several developmental neuropsychiatric
disorders including depression, stress-related anxiety, autism, OCD, and schizophrenia. The studies proposed
here are motivated, in part, by our discovery of changing dependencies of continuously expressed 5-HT
neuron terminal effector genes on Pet1 as 5-HT neurons mature. We unexpectedly found that Pet1’s terminal
selector control of 5-HT synthesis genes is largely switched off in the early postnatal period and instead Pet1
switches to controlling the upregulation of neurotransmitter GPCR genes, Htr1a, Adra1b, that are needed for
afferent synaptic modulation of 5-HT neuron excitability. These recent observations have led us to suggest a
new principle that we have termed “terminal selector target switching”. We suggest that as postmitotic neurons
progress through life, continuous terminal selector regulated transcription is not static, as is the prevailing
assumption. Instead, we hypothesize that terminal selector regulated transcription is highly dynamic in which
regulatory factor interactions with target genes are remodeled as postmitotic neurons mature. We hypothesize
the remodeling of regulatory interactions is rooted in the temporal remodeling of postmitotic neuronal chromatin
architecture. In Aim 1, we will investigate Lmx1b’s control of early postnatal 5-HT gene expression to
determine whether postmitotic target switching is a general property of 5-HT terminal selectors. In Aim 2, we
will use our newly developed 5HT-ATAC-seq protocol to uncover the temporal dynamics of 5-HT open
chromatin as 5-HT neurons develop and mature from fetal to early postnatal stages of life. Specifically, we will
address these questions: Do open chromatin states undergo maturational changes in parallel with the
maturation of 5-HT neuron transcriptomes? Do switches in target dependence result from gene specific
changes in open chromatin? Aim 3 will investigate a plausible potential mechanism through which developing
5-HT gene expression patterns are controlled: Terminal selectors, Pet1 and Lmx1b, directly act to control the
maturation of 5-HT neuronal open chromatin states. Understanding how terminal selectors control postmitotic
neuronal gene expression may illuminate potential neurodevelopmental disease mechanisms that cause
aberrant neuronal gene expression and defects in neuronal maturation.

Public health relevance
Project Narrative Control of serotonergic gene expression is of general interest as serotonin has wide-ranging modulatory effects on central neural circuitry and altered serotonergic gene expression, brought about by either genetic or early life environmental stressors, has been implicated in several neuropsychiatric diseases including depression, stress-related anxiety disorders, autism, OCD, and schizophrenia. The objective of the proposed research is to introduce assays of chromatin architecture to the study of serotonin neuron development and determine whether continuously expressed developmental neuronal transcription factors control gene expression through the regulation of open chromatin states. We will investigate previously unaddressed fundamental questions about how continuously expressed neuronal transcription factors control gene expression as postmitotic neurons progress through life, which may provide fundamental knowledge about underlying mechanisms of neurodevelopmental disorders in which gene expression trajectories are thought to be altered.